Metabolically improving the generation, function, and persistence of therapeutic T cells for the treatment of cancer

Project Summary
Immunotherapy has shifted the paradigm in the understanding and treatment of cancer. Within this arsenal of
new treatment strategies, adoptive cell therapy (ACT) has shown great promise; however, several barriers to
efficacy remain. One major hurdle is the high metabolic requirements of T cell anti-tumor cytoxicity within the
nutrient-poor tumor microenvironment (TME). Current culturing strategies used to generate high numbers of T
cells in vitro exacerbate this problem by using hyperglycemic and hyperoxic culture conditions. This strategy
favors the metabolic needs of T cells during expansion but ignores their metabolic requirements for persistence
within the TME. Our preliminary data indicate that treatment with the pyruvate dehydrogenase kinase 1 (PDHK1)
inhibitor dichloroacetate (DCA) during in vitro expansion of therapeutic T cells maintains therapeutic T cell
proliferation while improving anti-tumor clearance in vivo. Intriguingly, transcriptomic analysis of DCA-treated T
cells reveals a downregulation of interferon-stimulated genes (ISGs) seen in response to mitochondrial DNA
(mtDNA) damage. We hypothesize that DCA shunts glycolysis in a manner that re-directs metabolism to
a more oxidative state and thus prevents T cell mitochondrial stress and mtDNA releases during initial
expansion allowing for more fit T cells pre-infusion. Within this study, we aim to determine how DCA’s
metabolic effects and abrogation of ISGs contribute to improved anti-tumor efficacy. Determining the mechanism
of action of DCA on therapeutic T cells will not only inform the field of the benefits of using DCA as an in vitro
culture supplement for the generation of more efficacious therapeutic T cells, but will also allow for a better
understanding of the biological requirements for T cell function overall.

Public health relevance
PROJECT NARRATIVE Adoptive transfer of in vitro-expanded cancer-specific T cells allows for augmentation of the endogenous anti- cancer immune response in some, but not all, cases. The long-term consequences of hyperglycemic in vitro culture conditions on therapeutic T cell metabolism and function remain under-explored. This proposal highlights several mechanisms by which hyperglycemic culture conditions decrease therapeutic T cell efficacy as well as identifying in vitro glycolytic remodeling as a means of rectifying these shortcomings.